Integrated prediction of cardiovascular events by automated coronary plaque and pericoronary adipose tissue quantification from CT Angiography

PROJECT SUMMARY
From parent grant:
Coronary artery disease remains the leading cause of death worldwide, and more than half of the individuals
suffering myocardial infarction (heart attacks) have no premonitory symptoms. Studies of patients with coronary
artery disease have traditionally focused only on the severity of narrowing (stenosis) of the coronary arteries by
atherosclerotic plaques, rather than the adverse features of coronary plaques which are predisposed to rupture
and precipitate myocardial infarction. Coronary CT Angiography (CTA) is a noninvasive test that allows
assessment of both coronary stenosis and plaque characteristics. Currently, however, CTA is interpreted visually
for stenosis. Quantitative measurements of CTA stenosis severity and plaque features are not part of current
clinical routine.
In this project we propose to automate, using artificial intelligence (AI), the measurement of coronary plaque
characteristics and inflammation for patients undergoing coronary CT Angiography (CTA), a first-line noninvasive
diagnostic test for chest pain. We further propose to accurately predict future major adverse cardiac events (such
as heart attack), by integrating clinical data, CTA-measured coronary plaque and inflammation, using AI, in
prospective trials and multicenter CTA registries. We propose three specific aims:
1) To refine, expand and automate measurements of coronary plaque and lumen for the entire coronary artery
tree, and to standardize measurement of plaque changes in serial CTA;
2) To evaluate the prognostic value of automatically-quantified plaque features and PCAT characteristics for the
prediction of future MACE in the prospective SCOT-HEART trial and multicenter CTA registries;
3) To develop and evaluate with full external validation a new automated patient risk score—combining patient
clinical data, CTA-measured quantitative plaque features and PCAT characteristics, using machine learning—
for the prediction of future MACE events in the prospective SCOT-HEART trial and multicenter CTA registries.
The proposed work will enable automated, multi-faceted and reproducible analysis of plaque, stenosis and
PCAT from CTA, combined with objective risk scores reflecting likelihood of adverse cardiovascular events. This
work will provide a novel, personalized, real-world paradigm that objectively and accurately identifies
individual patients at risk of future cardiovascular events, from routine CTA imaging.
Additionally:
In this research supplement, we propose 1) to compare quantitative plaque characteristics among different ethnic
groups in asymptomatic patients from a prospective multi-ethnic registry, and 2) to establish reference ranges
for coronary plaque measurements from all asymptomatic patients in Aim 1, with prognostic validation in
prospective studies.

Public health relevance
PROJECT NARRATIVE From parent grant: In patients who are at risk of developing a heart attack, imaging of the heart with coronary Computed Tomography Angiography (CTA) allows doctors to noninvasively assess the narrowing of the coronary arteries caused by coronary plaque deposits, as well as the coronary plaques themselves. The researchers propose to develop and validate novel computerized scores derived from real-world CTA and clinical patient data using artificial intelligence, that will automatically identify the patients who are at highest risk of suffering a heart attack or cardiovascular death. Additionally: In this research supplement, we propose to accurately and rapidly measure, using artificial intelligence, the amounts and type of coronary plaque in a diverse multi-ethnic population; and to establish reference ranges for coronary plaque from subjects with no chest pain, for the prediction of heart attack.